Algorithms and Software for the Assembly of Metagenomic Data

Abstract
Through this proposal, we will develop new computational tools for reconstructing nearly-
complete microbial genomes from complex mixtures, as well as their strain structure. We
will build upon our initial successes in developing metagenomic assembly algorithms capable of
characterizing strain variants (7, 8), as well as upon our experience in using co-abundance across
samples to link/bin together genes originating from the same organism (9). In addition, we will
develop algorithms able to use information generated by emerging technologies, such as
chromosome conformation information generated by Hi-C (10-12), or information about DNA
modifications as generated by new nanopore sequencing devices(13, 14).

Public health relevance
Metagenomics studies are starting to elucidate the roles microbes play in human health and disease. This proposal will enhance future metagenomic studies by providing full featured, efficient, and robust algorithms and tools for reconstructing the genomes and metagenomes from high-throughput sequencing data.